Building Interdisciplinary Research Careers in Women's Health

ABSTRACT
The Vanderbilt-Meharry BIRCWH Program seeks to increase the pool of well-prepared investigators dedicated
to expanding knowledge about women's health via advances in sex and gender biology. Our scholars conduct
research across five thematic areas of exceptional institutional strength emphasizing five methodologic
approaches to actualize personalized prevention, diagnostics, and therapeutics for girls and women.
Leveraging a tradition of research excellence, scholars have access to many ongoing cohorts taking a lifespan
approach, existing interdisciplinary units in all of our thematic areas, and large-scale clinical and population-
level data linked to DNA and biospecimens, including prominent consortia. This environment creates synergy
for robust mechanistic and therapeutic research to deliver discoveries both inside and outside the lab. Our 36
former and current scholars conduct research as varied as immunologic and genetic aspects of lupus, gender
differences in outcomes of intensive care unit care, sex differences in resilience to Alzheimer's, and role of sex
hormones in T cell differentiation and cytokine expression in asthma onset and severity. Scholars are 81%
women and 28% identify with minority race/ethnicity, sexual orientation, or disadvantaged status historically
underrepresented in research. Nearly all remain in research. During training, scholars average 8 publications a
year, and alumni have been awarded 107 extramural grants worth over $50 million total. BIRCWH Scholars
are grounded in fundamentals of women's health and sex differences research, prepared to lead collaborative
teams, trained to effectively deploy innovative interdisciplinary approaches to attack and solve problems, and
committed to pursuing research that optimizes the health of all women. Scholars are selected by competitive
review of applications from early career faculty. Training is tailored to the individual scholar guided by
structured interdisciplinary mentorship and is overseen by a trio of Co-PIs who are all former BIRCWH
Scholars. Program resources are further extended by myriad institutional resources that ensure our
researchers thrive. Scholars form a mentoring panel, participate in weekly BIRCWH work-in-progress sessions
and seminars, receive formal evaluation twice a year, attend twice-monthly career development seminar series
with other K-awardees, and are regularly exposed to case studies on responsible conduct of rigorous and
reproducible research. They have access to: 1) an array of cores; 2) biostatistics consults; 3) manuscript
preparation groups; 4) technical editing of completed products; 5) studios with experts to vet scientific ideas,
aims, and research designs; 6) intramural pilot funding; 7) grant writing support including grant workshops, a
library of funded grants, and internal study sections; and 8) new expert consultations to design fully
individualized training plans termed Pathways. We deploy evaluation tools to continuously enhance our
program with oversight by an advisory committee and site visitors. Combined, this ensures we carefully
support excellence and build diversity in the next generation of women's health researchers.

Public health relevance
PROJECT NARRATIVE Our objective is to develop a diverse pool of well-prepared interdisciplinary investigators focused on advancing knowledge about women's health, the influence of sex and gender on health and disease, and the causal underpinnings of inequities in access and health outcomes. The strategic focus of the Vanderbilt-Meharry BIRCWH is to integrate the study of sex/gender differences and disparities in women's health into thriving research programs across the scientific spectrum, to deepen our understanding of sex/gender biology and actualize personalized prevention, diagnostics, and therapeutics for girls and women.